The development of visual behavior in infancy

Project Summary
Despite decades of research on infants’ visual processing, little is known about how their development reflects
changes in the visual input they receive. Throughout infancy, the view of the world changes as infants become
able to shift their posture from lying on their back to sitting, or from crawling to standing and walking. However,
researchers have primarily examined infants’ visual attention when viewing images taken from an adult
viewpoint. The long-term objective of this project is to provide understanding into the nature of the
development of infants’ visual attention given these changes in visual input. That is, because infants rely even
more heavily than do adults on visual processing to gain information about the world, understanding how their
attention develops considering these changes in viewpoint is critical for a complete understanding of healthy
development. To accomplish this objective, this project will address 3 specific aims. First the research team will
conduct work to compare infants’ visual attention to scenes from a familiar point of view (i.e., from a lying on
the ground or crawling perspective) versus from a relatively unfamiliar point of view (i.e., from an adult standing
point of view). Second, the research team will investigate infants’ visual attention to dynamic scenes. Although
infants almost always have a dynamic view of the world as they move their heads and bodies, virtually all the
research on infants’ visual attention is with static images. Finally, the research team will examine the effect of
viewpoint in the context of other kinds of novelty. Infants’ looking behavior is active and allows them to sample
information about the visual world. By investigating how infants’ visual attention adapts to one point of view and
then adjusts when the infant achieves a different point of view, we can construct an understanding of how
changes in in the visual system influence what infants learn about the visual world. Accomplishing these aims
will not only provide insight into the typical development of the visual system in healthy infants but will also
provide insight into points of vulnerability in that development and how multiple factors influence that
development. In addition, because the research team will use complex visual arrays, such as natural scenes,
this work will provide information about infants’ attention in contexts that mimic the infants’ everyday
experience.

Public health relevance
Project Narrative The proposed research is relevant to public health because visual attention is central to healthy development in infancy. Visual attention is associated with atypical developmental trajectories in conditions such as William’s Syndrome, Fragile X Syndrome, Autism Disorder Syndrome, and Cerebral Visual Impairment. Thus, understanding how these systems interact and develop in typical development is relevant to both the mission of advancing our knowledge of how cognitive processes develop in healthy individuals and is important for understanding points of vulnerability as well as to identify and intervene with developmental disorders.